Targeting PPT1 in the Tumor Microenvironment

Project Summary – Project 2

Therapy resistance in melanoma is a major hurdle to improved survival. This project will determine if therapy
resistance can be reversed by targeting the lysosomal enzyme protein palmitoyl thioesterase 1 (PPT1).
Autophagy is a lysosome-­dependent pathway that promotes tumor growth and resistance to therapy in
melanoma. Autophagy inhibition with chloroquine (CQ) derivatives augments the efficacy of many anticancer
therapies, but has limited activity as a single agent. Clinical trials involving HCQ in melanoma show
promising activity but concerns have been raised about the potency of HCQ, and its poorly understood
mechanism of action. We have prepared dimeric antimalarial compounds that are 10-­1000 fold more potent
in vitro and in vivo than CQ or HCQ. Dimeric quinacrines (DQs) (Rebecca Cancer Discovery 2017) and
dimeric chloroquines (DCs) (Rebecca Cancer Discovery in revision) look especially promising as both tool
compounds and potential clinical drugs. In the current cycle, we have found that extending the linker length
of these dimeric compounds increases lysosomal localization and anti-­melanoma activity. These DQs and
DCs with longer linkers as well as CQ were used to pull a new lysosomal target, PPT1, which is
overexpressed in cancer, especially in metastatic lesions. Efforts to target the lysosome and autophagy in
cancer cells have focused on the effects within cancer cells but recent literature suggests targeting this
pathway in immunosuppressive cells within the TME also contributes to antitumor activity. We will leverage
innovative collaborations with Projects 1, 3 and 4 and heavy support from the P01 cores to understand the
effects of PPT1 inhibition in both tumor cells, the interaction between tumor cells and fibroblasts, tumor
associated macrophages and T cells. The proposal is based on extensive new preliminary data in response
to the reviewers’ critiques from the September 2017 submission. We will test the hypothesis that targeting
PPT1 in tumor cells and macrophages overcomes therapy resistance in melanoma through completion of 3
aims: Aim 1 will develop innovative new compounds by introducing heteroatom substitutions into the linker,
and developing the first ever dimeric ferroquine derivatives that could have better penetration in the acidic
TME. We will also develop a novel assay for PPT1 that is compatible with live cells and animal studies. Aim
2 will leverage collaborations within the P01 to study the role of PPT1 in blocking lipid trafficking from aged
fibroblasts to melanoma cells and reversing resistance to targeted therapy. Aim 3 will study the effects of
PPT1 inhibition on tumor cell interactions with T cells and macrophages in 3D culture, immunocompetent
mouse models, and a new conditional KO model of Ppt1, with the goal of reversing resistance to
immunotherapy. The impact of these studies will be to unravel a deeper mechanistic understanding of the
consequences of lysosomal inhibition within the TME, which will support clinical development of these agents
in the future. Knowledge gained will ultimately lead to improved patient outcomes.

Public health relevance
Project Narrative – Project 2 This project will address a critical unmet need for new therapeutics for treat refractory advanced melanoma patients. We will utilize new chemical approaches to determine how best to inhibit a new target in melanoma we have identified, PPT1. We will utilize the P01 platform to study the effects of PPT1 inhibition both in the melanoma cell and its impact on the tumor microenvironment.